A novel inhibitory target for temporal lobe epilepsy

ABSTRACT
Temporal lobe epilepsy is the most common form of epilepsy in adults, and new treatment options are
needed. Using viral vectors and intersectional genetic approaches in transgenic mice, we are able to
selectively label and manipulate a unique subpopulation of NOS-expressing inhibitory neurons (referred
to in this proposal as “NPINs”) which our preliminary data indicate may be excellent targets for
intervention in temporal lobe epilepsy. The experiments outlined in this proposal provide a basic
characterization of NPINs in healthy and epileptic animals, and test the hypothesis that on-demand
optogenetic activation of NPINs will inhibit seizures in a mouse model of temporal lobe epilepsy.
Investigation of neuronal circuits and their constituent cell-types improves our understanding of
neurological disorders including epilepsy, and allows for the informed design of new treatment options.
Our preliminary data indicate that NPINs provide inhibition within the hippocampus and have
extrahippocampal projections, including to the frontal cortex. Within the hippocampus, our preliminary
data shows that NPINs provide strong, broad, and long lasting inhibition, placing NPINs in an ideal
position to alter network activity. Oscillatory activity, including theta, plays an important role in
hippocampal physiology, and coherent oscillations are important for coordinated information transfer
and predict task performance. Our preliminary data indicates that NPINs are able to induce theta
oscillations preferentially, and we further hypothesize that NPINs will increase the coherence of theta
within the hippocampus and between the hippocampus and frontal cortex in healthy animals.
Importantly, NPINs’ apparent ability to provide broad and strong inhibition also suggests that on-
demand optogenetic activation of NPINs may be an effective strategy to inhibit seizures in chronically
epileptic animals. Further supporting this strategy, our preliminary data demonstrates that in chronically
epileptic animals NPINs persist despite a reduction in overall number and continue to provide strong
inhibition. Taken together, our preliminary data indicates that NPINs are a unique neuronal population
poised to have a major impact on hippocampal activity. By exploring NPINs in health and in epilepsy,
the experiments outlined in this proposal will provide a fuller account of hippocampal cell types and
circuitry, including GABAergic projection neurons, and improve our understanding and ability to treat
disorders including epilepsy. Given their ability to provide broad and strong inhibition, NPINs are
exciting as a possible therapeutic target in temporal lobe epilepsy.

Public health relevance
PUBLIC HEALTH RELEVANCE Temporal lobe epilepsy is the most common form of epilepsy in adults, and up to 40% of patients are not adequately treated with current treatment options. This proposal examines a novel inhibitory target for temporal lobe epilepsy.